A PILOT STUDY OF MENSTRUAL PHASE AND DEPRESSION SYMPTOMS IN ACUTE SMOKING ABSTIN

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The long-term goal of this study is to determine the mechanisms by which women have greater difficulty quitting smoking compared to men and to subsequently develop and test new innovative smoking cessation strategies specifically tailored to reduce smoking prevalence in women. To participate in this study females must between the ages of 18 and 40, have regular menstrual cycles, not be using any hormones, be willing to stop smoking for a short period of time and be willing to use nicotine nasal spray.